ACUTE EFFECT OF AMYLASE INHIBITOR TAKEN W/ MEALS BY NORMAL, OBESE AND DIABETICS

Specific aim is to determine the dose of what amylase inhibitor (WAI) that will effectively reduce amylase activity under stimulated conditions and determine if WAI by itself alters gastric or pancreatic secretion or carbohydrate metabolism in duodenal studies in 9 persons.